CCR Collaborative Bioinformatics Resource

The CCR Collaborative Bioinformatics Resource (CCBR) is an organizational umbrella which provides a mechanism for CCR researchers to obtain many different types of bioinformatics assistance to further their research goals. This entity pulls together many different bioinformatics expertise within NCI, with strengths in a broad range of bioinformatics topics. The CCBR currently is providing support to over 80 Principal Investigators within CCR and are working on 120 projects related to several different general areas, including support to a wide variety of cancer genomics areas. The newest efforts have been in the area of single-cell genomics. Since its inception in 2011, CCBR has played a progressively key role as an "ecosystem" for bioinformatics support in CCR. This conceptual ecosystem has formed relationships for scientific collaborations and for computational, logistical, and strategic support. This evolving model allows CCBR to strengthen its core service to CCR laboratories while fostering scientific collaborations with other service facilities and embedded bioinformaticians in CCR. The various scientific and operational collaborations create a virtual umbrella under which bioinformatics support is integrated across several logistical pieces of BACS/ABCS operations. These partnerships also act as a conduit for fostering ideas, solutions, and new opportunities.